Real-Time Blood Parameter Monitoring System

Project Summary
The purpose of this proposal is to acquire advanced equipment – Terumo CDI ® Blood Parameter Monitoring
System 550 – to benefit the users of the S.R. Light Surgical Research Laboratory. The S.R. Light Laboratory is
a core facility managed under the Section of Surgical Sciences at Vanderbilt University Medical Center
(VUMC). The core is directed by Dr. José Diaz MD, Research Associate Professor of Surgery and Director of
the Division of Surgical Research. The S.R. Light Laboratory provides hands-on preoperative, intraoperative,
and postoperative support for surgical experiments in various animal models including dogs, goats, pigs, and
sheep. Vanderbilt University Medical Center is a world-renowned institution for organ transplantation, and its
preclinical research programs also have a strong clinical focus on organs, including advanced techniques for
ex-vivo organ preservation and recovery, and artificial organ therapies including extracorporeal membrane
oxygenation. These clinical interests have also been reflected in the investigations that are supported by the
S.R. Light Laboratory. However, the current monitoring equipment offered by the S.R. Light Laboratory lags
state-of-the-art equipment used for clinical transplantation and artificial organ therapies. To continue meeting
these growing research needs, the S.R. Light Laboratory will need to expand its capability to not only provide
direct technical hands-on support, but also to provide access to such state-of-the-art equipment. Across these
ongoing projects, they all share the need for continuous hemodynamic and perfusion monitoring to acquire
blood data on pH, pCO2, pO2, hemoglobin, potassium, and other critical measures of health. Currently, the
investigators rely upon manual blood draws and analyses to measure these parameters to ensure animal
health. Not only are manual blood draws cumbersome and labor-intensive, but they also add financial cost due
to the rising cost of disposables to obtain blood gas measurements. The new equipment Terumo CDI will
provide continuous readings of blood gases, meaning that there is no added monetary cost after the first set
up, and real-time measurements will better inform surgical and clinical decisions during animal experiments.
The new shared equipment from Terumo will therefore bring the current NIH-funded research programs up to a
clinical standard of perfusion monitoring. For projects that span over multiple days, the CDI system will be
beneficial by providing longitudinal trends, and the equipment will also support research and innovation into
automated control of circuits. Furthermore, this equipment will also stimulate the start-up of research projects
by new faculty who are seeking new funding and would greatly benefit from this equipment. The S.R. Light
Surgical Laboratory will be able to continue supporting this growth of Vanderbilt’s organ research.

Public health relevance
Project Narrative This funding requests for a shared equipment that will provide continuous measurements of animal health based on blood content. Our large animal surgical laboratory has long supported researchers that use complex machines like the heart-lung machine, but these studies are high in labor and mental cost due to the repeated blood sampling needed to ensure that the animal is healthy. By bringing this real-time clinical monitoring capability into this surgical research laboratory, this new equipment will lower the amount of efforts required to run these studies, extend the duration of these experiments with minimal added costs, and open a new avenue of research projects into automation and telemonitoring of these device technologies.